PREVENTION OF FAT EMBOLISM DURING TOTAL KNEE ARTHROPLASTY BY KNEE LAVAGE

The investigators plan to evaluate the use of an extramedullary alignment system, as well as evaluate the embolic events by performing the procedure without the use of a tourniquet. Lavage of femoral canal has reduced the total embolic load, but this has yet to reach statistical significance.